Emerging role of oral spirochetes to promote neuroinflammation and dysfunction

Periodontitis is a common chronic inflammatory condition of the tooth-supporting tissue, affecting up 50% of the
population and two-thirds of the elderly in the United States. Progressive neurological deterioration during poses
a significant burden for the elderly population, with high prevalence of cognitive decline in those over the age of
85 years old. Emerging evidence suggests a link between poor oral health, cognitive impairment and neurological
conditions. The blood-brain barrier (BBB) and associated cellular milieu of the neurovascular unit (NVU) including
microglia, pericytes and astrocytes serve as a crucial interface for neuroimmune communication and
physiological maintenance of the central nervous system. Healthy aging is associated with normal physiological
changes in the integrity and function of both the BBB and NVU. Sustained dysbiotic chronic systemic
inflammation of periodontitis may contribute to prolonged neuroinflammation, functional cognitive impairment
and neurodegenerative dysfunction. Dysbiosis of the dental plaque microbiome community occurs during
periodontitis, with increased abundance of multiple species of Treponema spirochetes. Continued evidence
indicates positive correlation of Treponema species in dental plaque and their presence in brain and neurological
tissue of patients with cognitive disorders. Despite known extraoral relationships of these understudied
spirochete organisms, there is still a significant gap in knowledge of how oral bacteria mechanistically impact the
BBB and NVU to contribute to cognitive disorders. Our central hypothesis is that periodontal pathogens including
Treponema species promote glial activation with BBB dysfunction, and thus contributes to a significant
neuroinflammatory response and consequent neurodegeneration; playing a key pathophysiological role in
bacterial-induced modulation of the neuro-immune axis. We will test our hypothesis by completion of the
following specific aims: 1. Characterize the ability of oral spirochetes to promote blood-brain barrier (BBB)
dysfunction and 2. Assess the ability of oral spirochetes to drive an inflammasome-mediated neuroinflammatory
phenotype and transcriptional signature in glial cells of neurovascular unit. Understanding the underlying
mechanisms involved in the interaction between microbes, inflammation and cellular components of the nervous
system is vital for the early intervention and improvement of neurological disorders.

Public health relevance
Periodontitis (PD), cognitive decline and dementias (CD) are prevalent health burdens, with PD affecting approximately 75% of the US population over 65 years of age and CD occurring in more than 40% of those 85 years and older. PD is a chronic inflammatory condition of the tooth-supporting tissue and compelling evidence highlights the relationship of PD with poor systemic health and contributions to cognitive decline and neurodegenerative disorders, of which the periodontal pathogenic bacteria Treponema are linked. In this proposal, we will study cellular pathways targeted by Treponema to promote dysfunction of Blood Bran Barrier and neurovascular cellular components, with the goal to provide new foundational information to further characterize microbial pathogenic mechanisms driving neurological disease to positively impact public health.